Endothelial progenitor cells and neurovascular injury in the aging

Project Summary
The proposed study will investigate endothelial progenitor cells (EPCs) taken from blood samples from older
adults at risk for dementia due to aging, genetics, Alzheimer’s disease pathophysiological changes and/or
cerebral small vessel disease. Extensive studies have focused on brain and cognitive markers of resilience to
Alzheimer’s disease, but far fewer studies have focused on the role of potentially protective vascular factors such
as EPCs. Proposed studies will utilize blood markers of EPCs and will culture EPCs from older adult blood
samples to investigate whether EPCs may predict whether someone remains cognitively normal despite the
presence of Alzheimer’s and vascular brain changes or whether they begin to decline cognitively. Studies will
also investigate whether EPC levels predict cerebrovascular changes, including deficits in the integrity of the
blood-brain barrier. Finally, EPCs cultured from older adults with and without Alzheimer’s or vascular brain
pathological changes will be studied and compared in their ability to grow, function and form a blood-brain barrier
in a chip-based vascular microbrain model that mimics the cerebral microvasculature in vitro. Findings from in
vitro EPC studies will then be compared with findings from brain imaging measures of cerebrovascular function
and blood-brain barrier integrity.

Public health relevance
Project Narrative The proposed studies will investigate the role of endothelial progenitor cells (EPCs) in cognitive resilience among older adults who are at risk for dementia due to aging, genetics, Alzheimer’s disease pathophysiological changes and/or cerebral small vessel disease.